Advancing understanding of cardiac regeneration through comparative analysis across vertebrates

Project Summary
Cardiovascular disease is a leading cause of mortality in the United States. One hallmark of heart failure is the
reactivation of a “fetal gene program” involving increased expression of genes related to contractility, calcium
handling, and energy metabolism. Despite adopting fetal-like gene expression patterns, the failing adult heart
lacks the regenerative potential seen in prenatal mammals or certain species, such as fish and amphibians.
The lack of regenerative capacity in the adult heart means that tissue damage leads to maladaptive cardiac
remodeling, fibrosis, and eventual organ failure, rather than regrowth of the lost cardiomyocytes. This proposed
work aims to understand the loss of regenerative capacity in adult mammalian cardiomyocytes through the
lens of evolutionary and developmental biology.
My central hypothesis is that there is a core gene expression program enabling heart regenerative capacity
that is active in fetal mammals as well as lower vertebrates. In Aim 1, I will compare fetal, healthy adult, and
failing human hearts and the single-cell using both transcriptomic and open-chromatin data. This will enable
me to identify genes that are not reactivated during heart failure, hindering the return to a proliferative state. My
preliminary analyses of multiple single-cell transcriptomics datasets suggest that the differences between
healthy and failing hearts are small compared to the differences between fetal and adult hearts, and
furthermore, these gene expression differences map onto changes in chromatin accessibility.
In Aim 2, I will compare single-cell transcriptomics of fetal and adult human hearts with the adult and embryonic
hearts of multiple other vertebrate species. This will enable me to identify gene expression programs active in
species capable of cardiac regeneration in adulthood but not in those incapables. Integrating single-cell
transcriptomic data across multiple species presents its own unique challenges, but preliminary work indicates
that it is feasible to obtain an integration that balances species-mixing and separation of shared cell types.
Together, completion of this proposal will result in hypotheses for how the regenerative capacity of hearts is
conserved across vertebrates and how it becomes inactivated in adult mammals, bolstering the search for
improved therapeutic strategies for heart failure by reactivating regenerative potential.

Public health relevance
Project Narrative Reactivating cardiomyocyte regenerative capacity is a crucial avenue for heart failure treatment, but key questions remain in how cardiac regeneration is regulated in humans and other vertebrates. Addressing how other cell types influence cardiomyocyte metabolism and proliferation, as well as studying the conservation of cardiac regeneration across vertebrate evolution, will translate evolutionary and developmental biology insights into therapeutic strategies. I propose to compare human fetal heart development and cardiac remodeling during heart failure at the single-cell level, and expand this comparison to other vertebrates with known regenerative capacity, to identify evolutionary conserved mechanisms involved in heart metabolism and regeneration.